OvaReady: An automated microfluidic oocyte retrieval and denudation device

AutoIVF's OvaReady project, supported by Phase-II SBIR funding, introduces a groundbreaking automated
microfluidic technology aimed at transforming the In-Vitro Fertilization (IVF) process. By automating the isolation
and denudation of Cumulus-Oocyte-Complexes (COCs) from follicular fluid aspirate (FFA), OvaReady seeks to
enhance the efficiency, safety, and accessibility of IVF treatments. The technology's novel approach facilitates
a one-touch preparation of oocytes for Intracytoplasmic Sperm Injection (ICSI) or cryopreservation within a
closed system, minimizing exposure to environmental variations and improving treatment outcomes. This
innovation aligns with NICHD's priorities for developing infertility diagnosis and treatment tools in resource-limited
settings.
OvaReady's immediate impact is demonstrated through increased oocyte recovery and preservation of oocyte
quality, addressing the correlation between oocyte quantity and successful IVF outcomes. The system's
efficiency has been validated in preliminary studies, revealing its potential to surpass the performance of
traditional manual methods. Furthermore, OvaReady's design allows for decentralized IVF services, enabling
the collection and preparation of oocytes at satellite clinics, thereby broadening access to fertility treatments.
The Phase-IIB project aims to refine OvaReady for commercial and regulatory approval, focusing on ease of
use, scaling up production, and developing image processing algorithms for automated oocyte enumeration and
classification. This phase will also involve disseminating the technology to major U.S. clinics to gather supportive
data. By standardizing the oocyte collection process and lowering barriers to IVF access, AutoIVF envisions
OvaReady as a key player in the future of fertility treatments, paving the way for its successful market introduction
and adoption.
The OvaReady commercialization strategy includes a phased approach to regulatory approval, anticipating a
market launch by 2028 and profitability by 2031, with initial emphasis on leading U.S. clinics before expanding
to the European market. AutoIVF's vision and innovation, encapsulated in OvaReady, promise to transform IVF
by making fertility preservation and treatment more accessible, reliable, and cost-effective, heralding a new era
in reproductive healthcare.

Public health relevance
AutoIVF's OvaReady project aims to democratize access to IVF treatment by automating oocyte preparation, significantly reducing costs and operational complexities associated with traditional IVF methods. This project's public health relevance lies in its potential to enhance health outcomes by increasing the efficiency and success rates of IVF procedures and improving access to fertility treatments for a broader population. AutoIVF has successfully completed the feasibility stage of this innovative technology and progressing into product development and commercialization.